ShEEP Request for Super Resolution Laser Scanning Confocal Microscopy System

This application will support the purchase of a state-of-the-art microscopy system, a super resolution laser scanning confocal microscope (Olympus FV3000). This system will enhance the research program of 7 VA investigators and enable them to obtain microscopy images of cellular and subcellular events with unprecedented resolution (up to 120 nanometers). There is no equipment available on our campus for this purpose. Although our academic affiliate has comparable microscopy systems in core facilities, our VA investigators face obstacles in using them due to limited availability in scheduling which often lead to significant delays, and cumbersome commute to/from our affiliate with biological samples. Having this technology available on our campus will represent a major benefit to our VA researchers, providing exceptional microscopy capabilities. For example, 4 of the users study platelets (cells with diameter of 2-3 micrometers) and typically rely on electron microscopy to study their cellular components. The super resolution system will enable these researchers to obtain microscopy images of platelet shape and structure with unprecedented capabilities. The system contains 7 lasers, which will facilitate simultaneous imaging of multiple cellular targets, including identify their interactions. Further, the system will be particularly helpful for studies on cultured cells, with its inverted microscope design with high numerical aperture silicone oil objectives and a temperature, humidity, and carbon dioxide-controlled incubation chamber. This system will complement the existing core research equipment at our facility, and will provide a tremendous enhancement to our overall research program. This is expected to promote further collaboration among VA investigators as well as improve our efforts to recruit and retain talented investigators to our medical center.

Public health relevance
This application supports the purchase of a super resolution laser scanning confocal microscope (Olympus FV3000). This state-of-the-art system allows scientists to obtain microscopy images with exquisite detail, providing much higher resolution than existing similar instruments, thus bridging the gap between conventional microscopy and electron microscopy. It will represent a major enhancement to the research program of VA investigators studying diseases common in Veterans, including bleeding disorders, blood clots, diabetes mellitus, and chronic kidney disease, and will help foster collaboration with additional VA investigators. The long-term goal of their research is to develop improved therapies for Veterans with these and other serious conditions.